PEER INTERVENTION TO LINK OVERDOSE SURVIVORS TO TREATMENT (CTN-0107). 9/1/2020-7/3/2023. N01DA-19-2250. TASK ORDER 75N95020F00006 (TO17).

Peer Intervention to Link Overdose survivors to Treatment (CTN-0107).